Fernald Community Cohort: Research Resource for Environmental Epidemiology

The Fernald Community Cohort (FCC) consists of the 9782 persons who participated in the Fernald Medical
Monitoring Program (FMMP) from 1990-2008. The FMMP was an 18-year medical surveillance program for
community residents living near the former US Department of Energy uranium processing site at Fernald (near
Cincinnati), Ohio. Although eligibility for the FMMP was based on living within 5 miles of the plant, much of the
cohort never received radiation exposure beyond the background exposure received by the general population.
At the end of the examination program, the study was renamed the Fernald Community Cohort (FCC). This
cohort embraces the complexity of discovery in environmental health. Multiple components of the exposure are
captured through the questionnaire data and exposure pathway modeling. The large collection of blood and
urine biospecimens obtained throughout the 18-year period can be used to measure exposure, early biologic
effects and disease biomarkers, and the periodic comprehensive medical examinations accurately assigned
phenotype. This cohort can be used to study a wide range of exposures and their health outcomes. The FCC
has an established procedure for providing access to data and biospecimens, which have been shared widely
and have been used in 80 research studies, resulting in 35 manuscripts published in peer-review journals.
In this revised application, we incorporate biomedical informatics expertise to convert to codes standard
ontologies, create new portals to FCC metadata, and deposit our meta data into the NIH and other
repositories. Our Biomedical Informatics team will develop a new online portal for investigators to explore the
FCC individual and meta data (FCCPortal), which will also increase our efficiency in managing resource
sharing. We propose to:
Aim 1: Maintain the cohort while increasing the value to the scientific community, by updating health status
information, enrolling 800 “next generation” of cohort members and collecting their data and biospecimens,
maintain our biorepository with periodic quality assurance assessments, and increase communication cohort
members and with community physicians regarding our research activities and findings.
Aim 2: Enrich the cohort through obtaining new health outcome and exposure data, converting our codes for
medical terms, diagnoses, and medications to standard ontologies, developing new biomedical informatics
tools and by exploring the feasibility of using banked samples in new technologies(ccfDNA for DNA
methylation biosmarkers; exosomal miRNA for expression molecular markers).
After 25 years of follow-up, the FCC is a primed research resource. Resources are well documented,
including a website with detailed information, searchable data dictionary, and extensive biospecimen inventory
database. With funding from NIEHS, we will be able to both maintain this valuable resource and increase its
value of the cohort for investigating generational effects of exposures, and serve additional research projects.

Public health relevance
PROJECT NARRATIVE: The Fernald Community Cohort (FCC) consists of the 9782 persons who participated in the Fernald Medical Monitoring Program (FMMP) from 1990-2008. The FMMP was an 18-year medical surveillance program for community residents living near the former US Department of Energy uranium processing site at Fernald (near Cincinnati), Ohio. Because of the exposure pathway modeling, extensive collection of blood and urine biospecimens collected throughout the 18-year period, the periodic comprehensive medical examinations, and questionnaire data designed to assess environmental exposures as well as general health information, this cohort can be used to study a wide range of exposures and their health outcomes.